Role of Oxidative Stress in Pathogenesis of Fuchs Endothelial Corneal Dystrophy

Project Summary/Abstract
Fuchs Endothelial Cornel Dystrophy (FECD), a common age-related dystrophy, which is more prevalent in
women, is of unknown etiology. In FECD, corneal endothelial (CE) cell loss is accompanied by abnormal
extracellular matrix (ECM) deposition in the form of guttae. Our laboratory was the first to link oxidative DNA
damage and mitochondrial dysfunction in FECD pathogenesis. Specifically, we showed that DNA damage,
induced by ultraviolet-A (UVA) light, causes FECD in mice. Moreover, the UVA induced CE cell cycle arrest in
G2/M phase and cellular senescence. We identified the novel involvement of CYP1B1, the key estrogen-
metabolizing enzyme, in sex-dependent differences in CE susceptibility to UVA; and detected greater
mitochondrial DNA (mtDNA) damage in female mice. However, the mechanism of the observed greater
susceptibility of female mice to UVA-induced DNA damage is unknown. Building upon our previous findings,
we propose to investigate if UV light–induced oxidant-antioxidant imbalance leads to senescence and ECM
deposition by causing G2/M cell cycle arrest; and if this imbalance causes translocation of CYP1B1 into
mitochondria triggering greater estrogen-induced mtDNA damage in females. Gene array analysis revealed
downregulation of DNA repair genes in FECD; therefore, we will determine whether this leads to decreased
DNA damage repair during G2/M cell cycle arrest, triggering the cells to undergo either senescence or
apoptosis. Our study is significant, as the investigation sex-dependent mechanisms involved in oxidative
stress-induced cellular damage will provide new treatment targets for FECD. In order to achieve these aims,
we will use our newly developed non-genetic mouse model of FECD based on physiologic outcome of CE
susceptibility to UVA along with immortalized human CE cell lines, human aqueous fluid, and ex vivo
specimens of genotyped FECD donors. Our Specific Aims are: Aim 1: Investigate the role of UVA irradiation in
G2/M cell cycle arrest and induction of cellular senescence and ECM deposition in FECD. This aim is based on
the hypothesis that DNA damage leads to G2/M phase arrest and induces cellular senescence, which in turn
leads to aberrant ECM deposition in the form of guttae in FECD. Aim 2: Determine whether UVA irradiation
activates CYP1B1 and induces estrogen metabolism causing preferentially greater DNA damage in females.
This aim is based on the hypothesis that higher incidence and severity of FECD in women occurs due to UVA-
induced translocation of CYP1B1 into mitochondria, which triggers formation of reactive estrogen metabolites,
causing mtDNA damage. Aim 3: Determine the role of DNA damage response and DNA repair during UVA-
induced cell cycle arrest in FECD. This aim is based on the hypothesis that DNA repair deficiency during G2/M
cell cycle arrest determines whether cells undergo senescence or apoptotic cell death in FECD.

Public health relevance
Project Narrative Fuchs Endothelial Corneal Dystrophy (FECD) is the major cause of progressive blindness from corneal endothelial cell death and the second most common cause of corneal transplants performed on the elderly (>65 years old) in the U.S.; moreover, women comprise almost 75% of patients undergoing corneal transplantation for FECD. In FECD, corneal endothelium, a layer of cells whose primary function is to maintain corneal transparency, is hypothesized to have heightened susceptibility to the deleterious effects of oxidative stress, due to build up of reactive estrogen byproducts and deficient cellular repair mechanisms, causing formation of abnormal cellular deposits and progressive cell death. Understanding key regulators of these pathogenic mechanisms may facilitate development of pharmacologic treatment for FECD patients.